EOI::IMPLEMENTING THE PRESIDENTS DEPARTMENT OF GOVERNMENT EFFICIENCY COST EFFICIENCY INITIATIVE (MARCH 19, 2025)::EOI NOTICE OF TERMINATION FOR CONVENIENCE PATHOLOGY MONITORING OF AGED RODENT COLONIES

Aging